Regional Medical Libraries for the Network of the National Library of Medicine: Region 7 & NPHCO

Overall
Abstract
The Lamar Soutter Library at the University of Massachusetts Medical School (UMMS)
proposes to serve as the Network of the National Library of Medicine (NNLM) Region 7 for the
2021-2026 cycle. UMMS has twenty years of experience serving as a host for an NNLM Region,
strong institutional support from the highest levels of UMMS administration, and long-standing
relationships with hospital, academic, and community partners; all of this makes UMMS
uniquely qualified and positioned to perform the functions of NNLM Region 7. The Overall
Component describes the regional framework for carrying out the mission of the NNLM,
engaging with existing and potential members, and the

Public health relevance
Overall Project Narrative Improving the public’s health is a significant initiative that involves a massive, complex mixture of professionals and organizations working together to achieve the mission of ensuring a healthier population. The mission can only be achieved when evidence-based information is made easily, openly, and freely available to healthcare professionals, the public health workforce, librarians, patients, researchers, educators, community-based organizations, and others dedicated to improving the health of local communities and the Nation. Region 7, through its network of partners, such as libraries, health-related institutions, and community-based organizations, provides the infrastructure, products, and services for the provision of equal access to authoritative biomedical information to those who need it, in the format they want, and at the desired time.